OPTIMIZING TIME-RESOLVED PUMP-PROBE EXPERIMENTS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Exploring experimental parameters for conducting ns pump-probe time-resolved measurements.